Developmental Funds

CCSG Developmental Funds are important to allow Roswell Park Comprehensive Cancer Center leadership
opportunities to pursue new initiatives that align with the strategic plan. The funds provide support for strategic
priorities that further the cancer center mission. CCSG Developmental Funds are usually leveraged alongside
institutional and philanthropic funds to support key faculty recruitment, shared resource development and
innovative pilot projects. During the current project period, CCSG developmental funds supported 9 new faculty
investigators; significant investment in shared resources to develop new techniques and to enhance new
utilization of shared resource services; and 24 pilot projects. These efforts have catalyzed collaborative efforts
within and across CCSG Programs that have yielded an impressive overall return on investment, measured as
publications and grants awarded as a result of the pilot research.
The CCSG/ Roswell Park Alliance Foundation Scientific Advisory Committee process administers and
oversees allocation of cancer center pilot project funding. Meritorious, high impact, high risk projects are
considered through this funding mechanism. This process has worked well to ensure internal, peer-review of
the applications. Candace Johnson, CCSG PI ultimately manages the allocation process and ensures
requests are in line with the Strategic Plan and cancer center priorities.
CCSG Developmental Funds add value by providing a flexible, dynamic source of funding that further the
overall mission and priorities of the center. Developmental Funds provide the opportunity to fund innovative
pilot projects, support new shared resources or enhance existing shared resources with new technologies, and
recruit key faculty in alignment with the strategic plan. During the next grant period, funds will support
recruitment, shared resources:
 Recruitments: The Center will recruit 2 key investigators per year. Developmental funds of $300,000 a
year will be used to support new investigators in each of the CCSG programs over project period.
 Shared Resources: The Center will use $100,000 a year to help develop new Shared Resources such
as Community Engagement Shared Resource, invest funds in new technologies to enhance existing
shared resources.
 Pilot Grants: Grants will be awarded to individual investigators through the Scientific Advisory
Committee (SAC) process, to each research program, and for Team Science. Strategic emphasis will
be placed on funding proposals that are collaborative and interdisciplinary in order to encourage large
multi-investigator initiatives and grants. Developmental funds of $200,000 a year will be used to support
pilot projects.